U-01 CONSORTIUM FOR THE STUDY OF CHRONIC PANCREATITIS,DIABETES AND PANCREATIC CANCER CLINICAL CENTERS

The continuation of the CPDPC will require the completion of the acquisition of subjects and
biospecimens, and sufficient follow-up to determine clinically relevant outcomes. Future efforts
for which the CPDPC was formed include includes biomarker development and validation, drug
development or repurposing, and therapeutic trials. Biomarker development and validation is
needed for such purposes as early diagnosis (chronic pancreatitis and pancreatic cancer),
prognosis, risk stratification and precision therapy. A second clinical need is the development of
better therapies for the diabetes associated with pancreatic diseases, and better management
of the pancreatic diseases themselves. We propose one biomarker study for the next phase of
the CPDPC, a study of sarcopenia as a biomarker for worse outcome in patients with chronic
pancreatitis. We also propose 2 potential trials for the next phase of the CPDPC, one focused
on developing more effective therapy for pancreaticogenic (Type 3c) diabetes and one for a trial
assessing timing of surgical intervention in painful chronic pancreatitis:
1. Finalize recruitment and follow-up of the PROCEED, DETECT, and NOD cohorts, and
incorporate strategies to increase recruitment of NOD subjects. Recruitment, retention,
and high quality data will need to be continued for all the cohorts. Recruitment into the
NOD protocol has been most challenging. We will utilize the OneFlorida clinical data
research network to identify partner health organizations within Florida to increase the
pool of eligible study subjects in both NOD as well as future clinical trials.
2. Characterize the prevalence, predictors, and impact of sarcopenia in patients with acute
relapsing pancreatitis and chronic pancreatitis, and the interaction with coexistent
diabetes; and establish strategies to identify and treat sarcopenia in these patients.
While sarcopenia has been identified as a common consequence of pancreatic cancer,
the prevalence of sarcopenia and clinical impact in patients with chronic pancreatitis is of
equal clinical import.
3. Implement a clinical trial within the CPDPC assessing the timing of surgical intervention
in patients with painful chronic pancreatitis or relapsing pancreatitis. Pain is the most
common symptom from chronic pancreatitis, the most common reason for intervention,
and the most important detractor from quality of life. Medical, endoscopic, and surgical
therapy are not highly effective, and the choice and timing of intervention for best
outcomes is not known. A trial comparing outcomes from surgical therapy (drainage or
resection) compared to endoscopic therapy in individuals with suitable anatomy who are
not dependent on opioids and have not developed continuous pain is likely to identify
more effective timing of therapy.
4. Determine the most effective and safest management strategy for pancreaticogenic
diabetes (Type 3c) in patients with chronic pancreatitis. These individuals have a mix of
insulin resistance and insulin deficiency, and may be malnourished. The lack of
pancreatic islet cell counterregulatory hormones make treatment-induced hypoglycemia
a very significant risk, and the coexistence of exocrine pancreatic insufficiency may
nutrient absorption less predictable. We propose a cross sectional analysis of patients
entered into PROCEED and DETECT cohorts, followed by a trial of two treatment
approaches (current standard medical therapy, versus newly available devices for
continuous glucose monitoring and insulin therapy) to determine the most effective and
safest strategies.
This proposed work spans critical areas of knowledge deficit: the role of sarcopenia in
chronic pancreatitis and relapsing acute pancreatitis, the most effective use of interventional
therapy for chronic pancreatitis pain, and the management of the complex metabolic profiles
of Type3c diabetes. These potential projects, if adopted by the continuation of the CPDPC,
will appropriately utilize the resources generated by the first iteration of the CPDPC and the
platform of clinical centers to realize the original goals and objectives of the CPDPC.

Public health relevance
Diabetes mellitus is a risk factor for pancreatitis and pancreatic cancer, as well as a consequence and complicating illness for both diseases. The ongoing work of the CPDPC aims for improving outcomes in these related and difficult to treat conditions, through earlier and more accurate diagnosis, more effective therapeutic options, and ultimately personalized approaches informed by more mechanistic understanding. The University of Florida will contribute to the ongoing work of the CPDPC consortium studying these disease relationships, by participating as a high volume center contributing to the ongoing patient cohorts and patient biological samples, as well as proposing and supporting future studies using the platform of the CPDPC for identifying accurate biomarkers and more effective therapies.